Optimizing Cognitive Assessment in DIAN with Smartphone-based burst testing

The Ambulatory Research in Cognition (ARC) study will leverage the increasing popularity of smartphones to
improve upon standard in-clinic cognitive testing, providing a robust characterization of cognition in participants
enrolled in the Dominantly-Inherited Alzheimer Network (DIAN) study. One of the most important and face-valid
indicators of Alzheimer’s disease (AD) is a change in cognition, but assessing cognition in-clinic has several
drawbacks. First, performance is influenced by day to day fluctuations in stress, fatigue, sleep patterns, and
mood. Second, the testing takes place in environments that are fundamentally different from where cognitively
demanding tasks are performed in daily life. Finally, by design, cognition is typically assessed very
infrequently, usually once per year or every two years (as is the case in DIAN). One solution would be to
increase the frequency of in-clinic testing, but this is impractical and burdensome, especially for DIAN
participants. DIAN participants come from families that have a ~50% chance of inheriting an extremely rare
autosomal dominant causal mutation for AD. Carriers of these mutations become symptomatic between 30 and
50 years of age, decades earlier than the more common sporadic form of AD. Most are still working and many
are primary caretakers for their young children and often for affected family members, therefore traveling to
sites more frequently for assessments is extraordinarily burdensome.
The ARC study will provide a solution to these difficulties by assessing cognition with an iOS and Android
app installed on ~248 DIAN participants’ personal smartphones. Every three months, participants will complete
extremely brief (<3 minutes each) testing sessions 4x/day over the course of one week. Tests are averaged
across the week to provide a score that captures and normalizes natural variability and dramatically increases
reliability. Pilot studies show that ARC assessments demonstrate extraordinary reliability, ranging from 0.86 to
0.98. Another advantage is the ability to measure variability within a day, across a week, and across the 3-
month intervals of assessments. We hypothesize that ARC assessments will be more sensitive than in-clinic
assessments to disease stage and AD biomarkers and that mutation carriers in DIAN will show more variability
in cognitive performance than non-carriers, even in the preclinical stages of disease. If successful, the
increases in sensitivity and reliability of ARC assessments will provide extraordinary statistical power to
characterize cognitive decline in observational studies of AD. In addition, ARC assessments could benefit
clinical trials by shortening trial duration and requiring fewer participants.

Public health relevance
People rely on cognitive abilities to function in situations and natural environments experienced in daily life, but research studies assess cognition in “one-shot” in a laboratory or clinical setting, which can yield unreliable results. This study will use a smartphone app to assess cognition with several brief (<3 min) tests per day over the course of a week in people at risk for Alzheimer’s disease (AD). If successful, this study will provide new insights into AD and could lead to faster results from clinical trials.